Behavioral-Biomedical Interface: Translational and Prevention Sciences Training

This predoctoral research training program focuses on transdisciplinary training of future behavioral scientists
organized around research concepts and methods at the interface of behavioral and biomedical domains. The
program's cross-cutting theme emphasizes translational sciences, accentuates facets of prevention science,
and engages both human and animal-model approaches to research. The predoctoral Behavioral-Biomedical
Interface Program (BBIP) stems from NIGMS's “Interface of the Behavioral and Biomedical Sciences” initiative.
BBIP engages trainees from three disciplinary units that are heavily involved in the behavioral sciences:
epidemiology, exercise science, and psychology. The behavioral and biomedical sciences faculty mentors and
BBIP trainees are working on health-related research problems linked for example to cancer, cardiovascular
health, children's behavioral and social-emotional health, diabetes, HIV, obesity and physical activity in
childhood and adulthood, stroke and brain injury, and substance abuse, as well as cross-content foci such as
implementation science, reduction of health disparities, addressing healthcare access and equity, and .
Providing the cross-disciplinary training are faculty mentors, laboratory hosts, program leaders, and course
instructors who bring to bear a broad array of disciplines and research areas such as epidemiology and related
public health areas, exercise science, genetics, geriatrics, environmental health sciences, neuroscience,
prevention science, psychology, and quantitative methods/biostatistics. BBIP training includes coursework,
integrated with doctoral degree curricula, in neuroscience, genetics, translational science, prevention science,
responsible conduct of research, methods to enhance rigor and reproducibility, and advanced statistical and
design methods. Trainees participate in two laboratory rotations exposing trainees to a variety of research
methods and perspectives, and take a behavioral-biomedical interface seminar course. All trainees immerse
themselves in mentored research throughout training. A Topic Sessions Series, taking place in BBIP's third
and fourth years, addresses scientific, methodological, career and professional development, and scientific
integrity topics. The program aims to foster a positive multi-disciplinary climate, encourage advanced
quantitative/statistical skill development, and inspire dissertation research informed by behavioral-biomedical
interface issues. This training program, which runs parallel to each trainee's discipline-specific doctoral degree
program, is designed to build capacity with respect to behavioral scientists who are sufficiently exposed to the
biomedical sciences to effectively contribute to multi-disciplinary teams engaged in research aimed at
understanding and preventing significant health disorders and conditions, and promoting positive health
outcomes.

Public health relevance
Project Narrative This institutional training grant supports the University of South Carolina Behavioral-Biomedical Interface Program, which helps to prepare future behavioral scientists to be better equipped to address the complex challenges inherent in health research. Pre-doctoral trainees in public health and psychology acquire important biological and biomedical foundations in concert with their behavioral science disciplinary training. This program adds scientists to the workforce who are able to more effectively translate research into understanding, preventing, and treating health disorders of major societal import.